Data Management and Analysis Core

PROJECT SUMMARY: DATA MANAGEMENT AND ANALYSIS CORE
The Iowa Superfund Research Program (ISRP) tackles a highly complex issue that requires a well-integrated
systems approach. The Data Management and Analysis Core (DMAC) will provide the expertise, tools, and
workflow optimization to support and maximize ISRP research results and impact. The DMAC and project
leaders will develop tailored Priority Analysis Plans with rigorous Quality Assurance to assure accuracy,
precision, representativeness, comparability, and reproducibility using appropriate statistical and analytical
methods. As a result, ISRP projects will make high-impact discoveries, publish in high-quality journals, and
provide timely scientific guidance to stakeholders regarding PCBs in the environment and their effect on
human health. DMAC will have five Specific Aims: 1) sustain and enhance data stewardship, FAIR-aligned
data sharing, and quality assurance for all ISRP projects and cores; 2) support ISRP projects and cores with
embedded expert statistical guidance and contributions; 3) develop novel statistical methods and associated
software for data analytic challenges that impact all ISRP projects, cores, and affiliated sciences; 4) support
the Research Experience and Training Coordination Core by providing guidance, resources, events, and
instruction on data science and informatics to trainees and investigators; and 5) provide integrative data
management and analytical foundations for research integration across the ISRP. Activities proposed under
DMAC Specific Aim 3 address the Superfund Research Program (SRP) mandates 2 and 3 which call for novel
statistical methods and tools to support detection and risk assessment. Activities under Specific Aim 5 address
SRP mandates 1, 2, and 4 by integrating data and methods from across the ISRP into cost-effective solutions
and strategies to comprehensively assess and reduce population-scale PCB risks to human health. This work
represents a unique opportunity to align existing resources to support interdisciplinary research. With the help
of our University of Iowa partners, the DMAC will be an early adopter of proven enabling approaches and
technologies for data management, data-sharing, reproducible research workflows, and informatics
investigation and training. DMAC will lead the application of biostatistics and informatics to support and
optimize ISRP research. We will provide expert staff, platforms, policies, and research support for all ISRP
projects and cores throughout the research process, including training and methods to maximize research
outcomes, applied solutions, replicable products, and sound evidence-based decision support. DMAC’s
activities will enhance full ISRP integration and catalyze effective development, refinement, application, and
sharing of innovative solutions generated by ISRP interdisciplinary and transdisciplinary PCB research.
DMAC’s centralized services, platforms, and policies, along with innovative new methods, will yield economies
of scale in effort and cost for data management, processing, sharing, analysis, and training.

Public health relevance
PROJECT NARRATIVE: DATA MANAGEMENT AND ANALYSIS CORE The Data Management and Analysis Core (DMAC) is designed to support the specific data management and analysis needs of Iowa Superfund Research Program (ISRP) projects and cores. DMAC’s primary objective will be to apply biostatistics, informatics, and data management to support and optimize the ISRP scientific health research process, training, and methods to maximize research outcomes, applied solutions, replicable products, and sound evidence-based decision support. DMAC will provide expert staff, infrastructure, services, software, and research support and synthesis in order to achieve these goals.